Dissecting the role of Aurora A kinase in patterning the cell cortex during cytokinesis.

PROJECT SUMMARY/ABSTRACT
Cytokinesis is the final step in mitosis and facilitates the physical cleavage of one cell into two
daughter cells. Animal cells achieve cytokinesis through the constriction of a cortical actomyosin
contractile ring that forms around the cell equator between the segregating chromosomes. Failure of
cytokinesis can lead to the formation of tetraploid cells that are thought to be an important intermediate
in tumorigenesis. To ensure equal partitioning of the genetic material, contractile ring assembly is
controlled by the anaphase spindle. The anaphase spindle sends two superimposed signals that
pattern the contractility of the overlying cortex; a signal from the central spindle that forms between the
separating chromosomes promotes contractility of the equatorial cortex, and a signal from the
centrosomal microtubule asters suppresses contractility of the non-equatorial cortex. Recent work in
C. elegans in my sponsor lab has implicated the mitotic kinase Aurora A in suppressing the
accumulation of contractile ring proteins on the non-equatorial cortex. However, whether this function
of Aurora A is conserved in human cells and the identity of the Aurora A target sites that mediate
suppression of cortical contractility are currently unknown. In the proposed work, I will determine
whether the role of Aurora A in patterning cortical contractility is conserved in human cells, use
molecular replacement techniques in C. elegans to identify the targets of Aurora A-mediated
suppression of cortical contractility, and determine how Aurora A suppression of contractility is
integrated with central spindle promotion of contractility to pattern contractile ring formation. In Aim1, I
will develop an assay to monitor the suppression of contractility on the non-equatorial cortex during
cytokinesis in human cells and use it to determine if Aurora A has a conserved role in this process and
whether ectopic targeting of Aurora A to the plasma membrane can suppress contractility. In Aim 2A,
I will capitalize on the advantages the C. elegans embryo offers for molecular replacement experiments
to perform an unbiased screen of cytokinesis regulators to identify the Aurora A target sites that mediate
the ability of centrosomal asters to suppress cortical contractility and will test identified regulatory sites
in human cells for conservation. In Aim 2B I will determine how Aurora A and central spindle-derived
signals are integrated to allow for the precise specification of contractile ring location and dimensions.
Collectively, this work will provide crucial insight into how Aurora A contributes to patterning cortical
contractility in dividing cells. As inhibitors targeting Aurora A are currently in clinical trials as potential
chemotherapeutic agents, understanding how the role of Aurora A in regulating contractility is related
to its functions in tumorigenesis has the potential to impact therapeutic strategies in cancer.

Public health relevance
PROJECT NARRATIVE During cell division, dividing cells are cleaved into two by the constriction of a contractile ring that forms a belt around the cell middle. The aim of the proposed research is to understand the role of the kinase Aurora A in ensuring that the contractile ring has the correct dimensions and forms at the correct equatorial location. Aurora A is overexpressed in many types of cancer; this work will help determine if the role of Aurora A in controlling contractile ring assembly is related to its ability to promote cancer development, which may contribute to ongoing efforts to target Aurora A in the context of chemotherapy.